Determinants of malaria transmission by submicroscopic gametocytemia

ABSTRACT
Even as malaria control efforts have achieved great reductions in malaria burden over the last decade, vast
numbers of asymptomatic infection exist and present an obstacle to malaria elimination. Most asymptomatic
carriers harbor parasites that are detectable by PCR but missed by current rapid diagnostic tests and
microscopy. These submicroscopic infections are one rationale for mass drug administration efforts. Yet the
role of submicroscopic infections in sustaining transmission is unknown. In fact, the malaria parasites
responsible for human to mosquito infection, gametocytes, may not achieve transmissible levels in the majority
of submicroscopic infections. We propose that a better understanding of gametocyte-mediated transmission at
low densities can lead to the design of better strategies to interrupt parasite transmission. Aim 1 of this
proposal will use mosquito feeding assays to define who within the asymptomatic reservoir is infectious to
mosquitoes, investigating the role of gametocyte density, sex ratio, and strain diversity in determining
transmissibility. We will use direct skin feeding to measure human to mosquito transmission, considered a truer,
more sensitive measure of human infectiousness than more commonly used membrane feeding assays. Aim 2
will determine the propensity for submicroscopic infections to persist and develop infective gametocytes over
time. In these two aims, next generation sequencing techniques will be used to distinguish individual
gametocyte strains to better understand how the composition of mixed gametocyte populations within
individuals changes over time and affects transmission, and whether intensive control efforts are selecting for
parasite strains that are able to persist at low densities without causing symptoms. This information is crucial to
understanding what factors sustain transmission from submicroscopic gametocyte carriers even as overall
transmission wans. Finally, Aim 3 deploys a field-relevant novel diagnostic test that has the potential to
reshape malaria elimination strategies. We hypothesize that the sensitivity of Gam-RDT, a lateral flow
immunoassay that detects a newly discovered gametocyte marker in saliva, approximates the gametocyte
density at which transmission occurs, making it a valuable field tool for identifying parasite carriers who make
up the infectious reservoir. We will conduct our study in Bagamoyo, Tanzania, an area where, although malaria
cases have decreased over the last decade, up to ~45% of schoolchildren continue to have asymptomatic
parasitemia detectable by highly sensitive PCR. Our team of experienced clinical trialists, leading malaria
entomologists, and international experts in malaria epidemiology and genetic diversity will establish the
evidence base for how malaria transmission from submicroscopic gametocyte carriers occurs in the face of
intensive control efforts that have successfully reduced the global malaria burden, but will likely not be enough
to eradicate this age-old human parasite.

Public health relevance
PROJECT NARRATIVE Malaria elimination will require a better understanding of the factors that promote malaria transmission from humans to mosquitoes, especially in persons with asymptomatic infection. Gametocytes are the parasite stages found in human blood that infect mosquitoes. By studying the infection of mosquitoes by persons with low-level gametocytes, this project will determine which asymptomatic persons contribute to transmission and pilot a field test to target these infectious carriers for treatment, as an alternative to mass drug administration.